Synthetic Lethal Targeting of SETD2 in Renal Cell Carcinoma

ABSTRACT
Clear cell renal cell carcinoma (ccRCC) accounts for ~75% of kidney cancers and is the 8th leading cause of
cancer death in the United States. After completion of The Cancer Genome Atlas (TCGA) Project, clinically
actionable mutations were identified in virtually every solid tumor. One major exception, however, is RCC,
where the current standard of care, checkpoint inhibitor and anti-VEGF therapy, does not take into account that
~50% of RCCs have mutations in chromatin regulators. After first-line therapy, response rates are 20% and
there are no FDA-approved therapies that target chromatin regulators, highlighting the need to identify how
loss-of-function genotypes can be therapeutically targeted. The epigenome is profoundly disrupted in cancers
including ccRCC. Aside from the near ubiquitous loss of VHL, the mutational landscape of ccRCC is dominated
by loss-of-function mutations in epigenetic regulators, including SETD2, BAP1, and PBRM1. SETD2 loss has
now been firmly linked to poor outcome and metastasis. The molecular phenotype of H3K36me3 deregulation
in SETD2-mutant ccRCC makes this an ideal scenario to study from the angle of synthetic lethality because it
induces global epigenetic changes that must be compensated for, creating unique vulnerabilities. Targeting
factors that exhibit genetic epistasis with known cancer mutations to drive a synthetic lethal phenotype is a
proven therapeutic approach. We performed an unbiased CRISPR/Cas9 screen to identify factors that exhibit
synthetic lethality with SETD2 loss-of-function. The epigenetic factor NSD1, a writer of H3K36me1/2 acting
through the H3K36 pathway, was identified. Based on these findings, we hypothesize that suppression of the
H3K36 axis in the form of its epigenetic writers (NSD1 in a SETD2 loss context) drives a synthetic lethal
phenotype mediated by distinct enhancer remodeling accompanied by expression defects incompatible with
cell viability. Identification of NSD1, which is part of a larger family of three related proteins (NSD1/2/3) within
the H3K36 signaling axis in turn, will lead to novel approaches for individualized therapeutics to target SETD2
loss-of-function, classically defined as ‘undruggable’. We will address this hypothesis with three aims. In aim 1
we functionally characterize the synthetic lethal phenotypes associated with H3K36 writers NSD1, NSD2, and
NSD3 in isogenic SETD2 ccRCC cell lines. In aim 2 we demonstrate the utility of pharmacologic inhibitors of
H3K36 signaling in driving synthetic lethality in SETD2-mutant cells and elucidate their biological
underpinnings. Finally, in aim 3 we validate the efficacy and specificity of genetic and pharmacologic targeting
of the H3K36 signaling axis to induce SETD2-mutant synthetic lethality in vivo using mouse models. Our
studies will shed new light on how epigenetic regulators and the H3K36 axis specifically, drive cancer and
metastasis when deregulated. This is expected to positively affect human health by generating preclinical
evidence for new ways to treat SETD2-mutant ccRCC that will minimize off-target side effects, and enhance
survival for patients with ccRCC, particularly those with more aggressive/metastatic disease.

Public health relevance
NARRATIVE Clear cell renal cell carcinoma (ccRCC) is currently the 8th leading cause of cancer death in the United States and is unusual for its high frequency of epigenome regulator gene mutations, including a gene called SETD2 that when mutated, is associated with reduced survival and metastasis. Identification of genes that act as redundant backups to known cancer mutations is a proven approach to identifying new therapeutic drug targets. Using this approach, called “synthetic lethality” we identified novel and druggable pathways that we expect to lead to a better understanding of how SETD2 loss drives ccRCC and new ways to therapeutically target tumors with this mutation.